Defining the Self-Renewal Program in Human Hematopoietic Stem Cells

PROJECT SUMMARY
Difficulty to expand self-renewing human hematopoietic stem cells (HSC) in culture or generate them from
human pluripotent stem cells (PSC) has hampered the use of in vitro engineered HSCs for therapeutic
purposes. Our data suggest that the failure to induce and maintain the correct transcriptional networks
governing HSC self-renewal during in vitro culture compromises the generation/expansion of fully functional
human HSC in an in vitro setting. Guided by the transcriptional profile of highly purified human fetal liver (FL)
HSC, we sought to identify key transcriptional regulators that govern self-renewal in human HSC, with the long-
term goal to develop new strategies to improve the function of in vitro derived hematopoietic cells. We
identified MLLT3/AF9, a component of superelongation complex (SEC) as a novel regulator of human HSC
stemness. MLLT3 is highly enriched in the self-renewing HSC during human development (FL), pre-natally
(cord blood, CB) and in the adult (bone marrow, BM), but becomes downregulated during HSPC differentiation
and in vitro culture. Lentiviral knockdown of MLLT3 in human FL and CB HSC resulted in loss of HSC function
in vitro and in vivo, while overexpression of MLLT3 greatly improved the ex vivo expansion and engraftment of
FL and CB HSPCs, and partially rescued the proliferative potential of hESC-derived HSPCs. An important
feature of MLLT3 is that it does not reprogram or transform hematopoietic cells, but only enhances the self-
renewal and proliferative potential of properly specific HSCs. We will now examine how MLLT3 co-operates
with transcription elongation machinery and epigenetic mechanisms to regulates its target genes and maintain
proper HSC stemness program (Aim 1). We will then examine whether rescuing MLLT3 levels in culture by
lentiviral overexpression or transient RNA electroporation increases the expansion of in vivo engraftable
human HSCs (Aim 2). Finally, we will determine the unique function of a hitherto uncharacterized shorter
isoform of MLLT3 that is also highly enriched in human HSCs, and may have an opposing function to the full
length MLLT3 (Aim 3). This proposal will help understand how MLLT3 functions as an upstream regulator of
“stemness” in human HSCs, and how its function in regulating HSC fate decisions may be modulated by the
different isoforms. These studies will not only increase our knowledge of the fundamental regulatory
mechanisms governing human HSC fate decisions, but also pave the way for developing novel approaches for
the ex vivo expansion and manipulation of HSC for therapeutic use.

Public health relevance
PROJECT NARRATIVE We sought for novel regulators enriched in human hematopoietic stem cells (HSC), and identified MLLT3 as a critical factor that enables proper regulation of HSC genes. Here we will examine how MLLT3 and its hitherto unstudied short isoform interact with transcription elongation machinery and epigenetic mechanisms to maintain HSC regulatory network and functional properties. These studies will provide new approaches to generating and expanding HSCs for the treatment of blood diseases.